Clinical Trans Valid: The Center for Advancing Point of Care Technologies in Heart, Lung, Blood and Sleep Diseases

American healthcare is rapidly evolving to a state where efficiency and quality in health care are
co-dominant drivers. Point-of-care technologies (POCT) are an important tool for providers and
patients to receive immediate feedback on critical health issues. In acute care settings, caregivers
need real-time POCT to guide treatment in rapidly changing circumstances; and in the outpatient
setting providers are seeking ways to engage patients with preventative measures and implement
precision medicine. The goal of CAPCaT is to develop and optimize novel POCT to improve the
diagnosis and management of heart, lung, blood and sleep (HLBS) diseases. The Clinical
Translation and Validation (CTV) core will be responsible for validating the prototypes and
establishing the feasibility of adoption of these devices in settings appropriate to the specific
technology being tested. Therefore, we will maintain a broad array of services necessary to
facilitate clinical research, and support the specific needs of individual projects.